MBQ-167 derivatives as antimetastatic cancer agents.

Metastatic disease is the primary cause of cancer mortality, but effective treatments remain elusive. Therefore,
our LONG-TERM GOAL is to address the CRITICAL NEED for more targeted strategies to treat metastatic
disease. The Rho family GTPases Rac and Cdc42 and their downstream effector p21-activated kinase (PAK)
are pivotal regulators of metastatic cancer cell migration and invasion; and thus, represent ideal targets for
prevention of metastasis. Rac and Cdc42 do not have to be overexpressed in cancer to drive metastasis,
because they can be over activated by oncogenic cell surface receptor signaling pathways. Therefore, we
developed MBQ-167, which inhibits Rac and Cdc42 activation by blocking GTP exchange without affecting
expression. MBQ-167 is superior to other known Rac/Cdc42 inhibitors, and inhibits cell and tumor growth,
metastasis and survival of metastases in breast and pancreatic cancer cell and mouse models at low
physiological concentrations. Moreover, MBQ-167 has an excellent safety profile in both rodents and dogs (both
non-GLP and GLP studies completed) up to 1000 mg/kg body weight and has acceptable bioavailability in rodent
and dog plasma and tumor tissue (IND submitted to the US FDA). The rationale for this application stems from
the PI’s SC3 GM084824 award (2008-2022), which resulted in ~25 publications, 3 patents, graduated 8 Ph.D.
students, and trained numerous graduate and undergraduate students, all of whom are underrepresented
minorities. During the present cycle of the SC3 award, we identified two new Rac/Cdc42 inhibitors, MBQ-168
and EHop-097, with enhanced efficacy compared to their respective parent molecules MBQ-167 and EHop-016.
This SuRE proposal will test the HYPOTHSIS that Rac/Cdc42 inhibitors are viable antimetastatic cancer
therapeutics in breast and pancreatic cancer. Aim 1 will demonstrate the efficacy, safety, and bioavailability
of Rac/Cdc42 inhibitors MBQ-168 and EHop-097 in pre-clinical mouse models using chemiluminescence
imaging of luciferase tagged breast and pancreatic cancer cells in mice from spontaneous and experimental
metastasis assays. Aim 2 will demonstrate the efficacy of Rac/Cdc42 inhibitors in ex vivo cultures of
patient tissues. Our innovative research design will use fresh breast and pancreatic cancer patient tissue (from
biopsies and surgery), in ex vivo cultures, to test for changes in cancer cell proliferation, immune cell infiltration,
and inhibitor efficacy following short-term vehicle, MBQ-167, MBQ-168, or EHop-097 treatment. Drug efficacy in
cancer cells and the immune cells infiltrating the tumor microenvironment (TME) will be assessed in situ via
immunohistochemistry, using specific antibodies to pharmacodynamic markers of Rac/Cdc42 efficacy, as well
as immune cells in the TME. The OUTCOME of this study will delineate the complex action of Rac/Cdc42
inhibitors in experimental mouse models and patient tissues and forward the translational development of
Rac/Cdc42 inhibitors in pancreatic and breast cancer. Moreover, graduate, undergraduate, and medical students
will be trained in cutting edge techniques and concepts of cancer drug development.

Public health relevance
Pancreatic cancer presents with a dismal 3% five-year survival rate at stage IV metastatic disease, and the survival rates for breast cancer drops from 90% to 20% when the breast cancers establish distant metastases. Therefore, this proposal will characterize two new metastasis targeted therapeutics in preclinical mouse models and fresh breast and pancreatic cancer patient tissue. This study promises to shift paradigms and impact metastatic cancer cure.